Resource Section

ABSTRACT: Resource Section
This proposal seeks renewal of 5 year support for the infrastructure, personnel, and resources of the Mutant
Mouse Resource and Research Center (MMRRC) at the University of California (UC) Davis (MMRRC-UCD).
Since its inception 25 years ago, the MMRRC-UCD has been one of the primary mutant mouse archive and
distribution repositories in the world. As the largest by repository holdings, orders fulfilled, and researchers
served of the 4 Centers in the MMRRC consortium, the MMRRC-UCD has assumed a position of leadership in
innovation and resource development. The MMRRC-UCD has introduced new products (e.g., KOMP knockout
first alleles in ES cells, CRISPR/Cas9 genome edited alleles in zygotes, patient genotype-specific mice, novel
disease mouse models) and initiated new services (e.g., ICSI, speed congenics, genetic variant modeling,
microbiome analysis, conditional ES cell injection, fast-track cryopreservation, multi-omic (transcriptome,
proteome, metabolome) analysis, distribution of mouse tissues) that have added scientific value to mouse
models submitted to the MMRRC, which in turn has enhanced utilization of the MMRRC by the scientific
research community. As a result, to date the MMRRC-UCD leads the consortium in the number of alleles
archived (51,142 out of 64,796), orders (14,501 out of 20,225), and investigators served (5,560 out of 13,651)
at 2,936 institutions in 26 countries. The MMRRC-UCD has leveraged its infrastructure and expertise to extend
its service role by contracting with categorical NIH institutes (e.g., NHGRI KOMP2 project), biotechnology
companies (Genentech), and several organizations (e.g., the BasH Consortium) to archive, distribute, custom
breed, genotype, and phenotype thousands of transgenic and knockout, gene-targeted ES cell lines, BAC-
transgenic, CRE, ENU-induced, CRISPR-edited, Collaborative Cross, and other mutant mouse collections. In
addition, the MMRRC-UCD has worked with its MMRRC consortium partners and NIH program staff to develop
and implement advertising and marketing strategies, database management and informatics applications,
website and online resources, customer and user services, operating procedures and protocols, and optimized
policies and practices for shared governance. Further, over the last several years, the MMRRC-UCD
completed several research projects in multiple areas that have enhanced operations of the resource, including
in cryopreservation, gut microbiome analysis, mouse analgesics, genetic variant modeling using
CRISPR/Cas9, COVID-19 modeling, and more. Over the next 5 years, the MMRRC-UCD looks forward to the
assignment of another ~250 mouse lines from the research community, providing users access to several new
services including Lung Function Analysis, ABSL3 Phenotyping, and Home Cage Phenotyping, and conducting
an innovative new resource-related research project to develop a long-term, dependable, reproducible, and
safe oocyte vitrification and cryorecovery method. By archiving and distributing research mouse products and
services effectively and efficiently, and by conducting applied research activities to improve operations of the
resource, the MMRRC-UCD aims to excel as a scientifically valuable biorepository for the biomedical research
community. Over the next 5 years, we shall focus our efforts on optimizing the quality of our resource, ensuring
its relevance to individual users, and seeking maximum performance for the benefit of all whom we serve.

Public health relevance
PROJECT NARRATIVE: Resource Section The Mutant Mouse Resource and Research Center (MMRRC) at UC Davis (MMRRC-UCD) is the flagship of the MMRRC consortium and serves a leading role in facilitating research by identifying, acquiring, evaluating, characterizing, cryopreserving, and distributing mutant mouse strains to qualified biomedical investigators. The MMRRC-UCD ensures that scientifically valuable transgenic, knockout, and other genetically-modified mutant mice, embryonic stem (ES) cells, hybridomas, mouse tissues, and other relevant biomaterials are maintained and made available and accessible for investigational use by researchers across the biomedical scientific community. The MMRRC-UCD provides expertise, infrastructure, resources and services to preserve mouse strains in perpetuity, protect them from catastrophic loss, mitigate against genetic and phenotypic drift, prevent pathogenic contamination and disease, add and enhance phenotypic characterization, and conduct resource- related research to advance, catalyze and accelerate the study of mutant mice as models of human disease. The MMRRC-UCD fosters and promotes discovery of new diagnostics, treatments, and prevention strategies against human diseases, optimizes reproducibility of studies, and assures scientific rigor and transparency.